Workshops and Coaching to Foster Career Skills in Newly Funded NIDDK Scholars

PROJECT SUMMARY
ABSTRACT: The broad goal of the University of Miami's Advanced Workshops and Coaching Network (AWACN)
is to enhance the stage-specific career development skills of newly funded, underrepresented minority NIDDK
researchers at the postdoctoral and junior faculty levels. Continued development of professional skills will foster
early career success and lay the foundation for a strong and rewarding career in academic research. Program
scholars will participate in a 3-day workshop hosted by the University of Miami's Miller School of Medicine.
Workshop curricula will be determined by pre-workshop needs assessment surveys allowing each workshop to
target needs of the scholar cohort and avoid overlap with strong programs at the scholars' home institutions.
Workshops will include didactic instruction, experiential activities and provide scholars with tangible outputs. All
workshops will be led by NIDDK-funded researchers at the University of Miami, or faculty with expertise in
transferable skills development. The latter will include effective negotiation tactics, strategies to combat
microaggression, and work/life balance. During the workshop each scholar will also meet their two coaches,
who, over the next two years, will provide guidance and support to the scholar. Coaches are all University of
Miami faculty with current research funded by NIDDK and who are trained mentors. One coach will match the
research type of the scholar (basic science, translational, or clinical research) and the other coach will provide a
broader perspective (e.g. a translational scientist will bring experience in moving basic science discoveries into
potential therapies). Coaches will meet remotely with their scholars approximately once a month by phone or
video conference to provide guidance on topics of the scholar's choice. Coaches will also strongly promote the
scholar's engagement in productive, substantive collaborations that lead to joint publications that then support
their recognition in their field and promote their career progression. The effectiveness of the workshops (Aim 1)
and extended coaching (Aim 2) will be evaluated using a outcome logic model. This model will assess the
effectiveness of the program components and resources on the scholars' career progression and satisfaction.
The evaluation process will also address whether an external workshop program and/or coaching network can
enhance career development programs at the home institution, and if present, counteract negative aspects of
the home institution's working environment. Dissemination of course content and anonymized results will include
publication on a dedicated website and publication of a peer-reviewed manuscript. Evaluation and dissemination
will be strengthened by working with the NIDDK Program Scientist collaborating on the project, and the Steering
Committee of Program Directors from all funded programs under RFA-DK-22-002 to administer a common
evaulation strategy and combine data from all programs into a comprehensive analysis and publication
describing these results.

Public health relevance
PROJECT NARRATIVE Racial and gender underrepresentation in biomedical research continue to be a major challenge in tackling many diseases, and this is especially true for those that fall under the NIDDK mission, which include diabetes, obesity, and chronic kidney disease. Capitalizing on the talents, insights, and interests of diverse groups of scientists are critical to addressing acute and chronic diseases that impact the health and prosperity of many Americans. We propose a workshop and coaching program to support and advise NIDDK awardees from underrepresented minorities at early career stages to foster their professional development and promote their impactful careers addressing disease mechanisms and therapeutic interventions.